Cyclotron Radiochemistry and Chemistry

Specialized Resource A - Cyclotron Radiochemistry and Chemistry (SR-A). lCMlC-3 is reliant on the production and supply of existing and novel radiopharmaceuticals and radiochemicals. In this Specialized Resource we will continue to generate a tool box of radiolabeled drugs based around 18F-tracers as well as drugs based on the longer-lived nuclides 64Cu, 86Y, 89Zr and 124I. This will allow us to augment the existing lCMIC-3 projects, the ICMIC Developmental Projects, ultimately resulting in the ability to get a better understanding of the biology of cancer and to perform personalized medicine in our patients. The Specific Aims of this Specialized Resource are as follows: (A) to undertake specialized radiochemistry and labeling chemistry in support of the ICMIC projects and developmental projects; (B) To function as an evolving resource - to provide (and design) new compounds as required as the ICMIC research matures; and, (C) to act as a central resource for the translation of new drugs to the clinical setting. The Aims will be achieved by providing state-of-the-art radiochemistry facilities (including a $25M expansion over the next 5 years) to the ICMIC projects and developmental projects with high grade, GMP prepared (if required) radiotracers. This Specialized Resource will also be developmental in nature; as new chemicals and radiochemicals are required by the Projects, this Specialized Resource will respond by producing novel compounds as requested.

Public health relevance
This Specialized Resource will provide services and expertise in chemistry and radiochemistry to all four of the Research Projects within this ICMIC. This Specialized Resource we will generate a tool box of radiolabeled drugs that will allow us to augment the existing ICMIC projects, the ICMIC developmental projects and the new ICMIC research programs, ultimately resulting in the ability to get a better understanding of the biology of cancer and to perform personalized medicine in our patients.